Prediction of Anticoagulant-Related Bleeding Risk in Patients with Cancer

Project Summary
Among patients with cancer, the risk of anticoagulant-related major bleeding is more than double that of
patients without cancer. These bleeds have a fatality rate of 7%. Current guidelines recommend indefinite
anticoagulant therapy in many patients with cancer and venous thromboembolism (VTE) with periodic
assessments of bleeding risk. However, no evidence-based models exist to quantify bleeding risk in patients
with cancer taking anticoagulants. In addition, recent trials have demonstrated effectiveness of direct oral
anticoagulants as primary prophylaxis for prevention of initial VTE in patients with cancer. Thus, there is a
strong need to balance the competing risks of VTE and anticoagulant-related bleeding in patients with
cancer. While there are models that quantify bleeding risk in non-cancer populations (i.e. atrial fibrillation, non-
cancer associated VTE) taking anticoagulants, they have not been validated in patients with cancer.
Quantification of bleeding risk in patients with cancer and VTE would allow for an evidence-based approach to
preventing and treating VTE by minimizing anticoagulant therapy in patients at high-risk of bleeding and
allowing for judicial use in patients at low-risk of bleeding. The overall objective of this study is to develop a
prediction model for anticoagulant-related bleeding in patients with cancer and VTE on anticoagulant therapy
and to calibrate that model in cancer patients at high-risk of VTE being considered for primary
thromboprophylaxis with anticoagulant therapy. We will accomplish our overall objective through the following
specific aims: (1) validate eight existing bleeding prediction models in a cohort of 7489 patients with cancer
and VTE receiving anticoagulant therapy, (2) refine and validate a cancer-specific prediction model to quantify
risk of anticoagulant-associated bleeding in patients with cancer on anticoagulant therapy for VTE, and (3)
calibrate the refined bleeding prediction model in a cohort of patients with cancer receiving primary
anticoagulant thromboprophylaxis enrolled in two randomized trials (AVERT and CASSINI). These aims will be
addressed with an expert research team in the areas of bleeding, VTE (especially in patients with cancer) and
development and implementation of risk prediction models. This proposal is innovative as it addresses a
current gap in the management of patients with cancer with or at high-risk of VTE by developing a prediction
model to quantify the risk of the intervention (anticoagulant therapy) to inform and guide patient care. This
research will be significant because it has the potential to decrease anticoagulant-related bleeding and thus
bleeding related morbidity and mortality in patients with cancer.

Public health relevance
Project Narrative Patients with cancer on blood thinners are at high-risk of bleeding, including bleeding related death. Bleeding risk can be predicted through prediction models in non-cancer populations, but no prediction model is validated for use in patients with cancer. We will develop a prediction model to quantify the risk of bleeding in patients with cancer, which will allow healthcare providers to tailor length and intensity of anticoagulant therapy to individual risk of bleeding.